Morphology/Cell Culture Core

The purpose of the Morphology/Cell Culture Core will be to perform tissue processing, sectioning, histochemical and immunohistochemistry staining as well as prepare primary-culture airway epithelial cells for Program investigators and their associates. The Core will be staffed by experienced research technicians to adequately provide these services and will function within an established Morphology and Immunopathology Core that is fully equipped and currently supported by numerous other NIH/NHLBI programs and a Washington University School of Medicine local grant. Similarly, the cell culture component of this proposal will be incorporated into an established Airway Epithelial Cell Core that is fully equipped and currently supported by a Childrens Discovery Institute grant through Washington University School of Medicine. The Morphology/Cell Culture Core will be an integral and essential component of this Program Project Grant application because each of the individual projects proposes numerous experiments that require the services provided by the Core.